A Targeted Nanomedicine Prototype Against Enzalutamide-resistant Prostate Cancer

ABSTRACT
Eight percent of patients diagnosed with prostate cancer progress to lethal metastatic disease. Development of
resistance to androgen-deprivation therapy and eventually, to last line chemotherapeutics such as
enzalutamide (ENZ), contribute to lethal, metastatic prostate cancer. While interest to identify tumor-specific
molecular signatures, termed precision medicine, is gaining popular favor, it requires identification of
physiologically accessible targets. By diverting the function of a molecular tumor target by conventional anti-
cancer drugs, rates of tumor growth are expected to decrease; however, this does not take into account
acquired drug resistance mechanisms which are dependent on systemic drug stability, solubility or toxicity.
One method to stabilize poorly soluble and/or highly toxic drugs, and potentially overcome resistance, is to
encapsulate drugs in nanoparticles (NPs) to prevent their degradation and enhance their circulation time.
Moreover, accumulation of loaded NPs at the tumor site can be improved by adding tumor-specific targeting
moieties that induce NP endocytosis, thereby improving the therapeutic index while minimizing collateral
damage to healthy cells. A prostate tumor-specific biomarker, the 78 kDa glucose-regulated protein (GRP78),
was identified by the Pasqualini and Arap team by screening antibodies from prostate cancer patient sera.
GRP78 is a biomarker of disease progression and, crucial to our proposed research, we recently identified
human recombinant anti-GRP78 antibodies with optimal in vivo tumor targeting. In this proposal, our objective
is to generate GRP78-targeted NPs against ENZ-resistant prostate cancer. We will employ the novel, modular
“protocell” platform developed by the Brinker team. Protocells consist of a porous silica core, which can be
engineered to accommodate varied and combination cargos, encapsulated within a supported lipid bilayer that
protects and retains the cargo, and provides a biocompatible surface for conjugation to targeting and/or
trafficking ligands. The Brinker team demonstrated exceptional stability of targeted, first-generation protocells
in vivo with specific binding and cargo delivery to individual circulating leukemia cells. Instead of delivering
chemotherapeutic drugs that work at the protein level, we propose to deliver small interfering RNAs (siRNAs)
directed against the long non-coding RNA, PCA3. We showed that interfering with PCA3 inhibits growth of
human prostate xenografts. Guided by predictive modeling conducted by the Cristini team, our modular
GRP78-targeted protocells will be designed to package PCA3 siRNAs to selectively bind to GRP78-expressing
prostate cancer cells, and deliver PCA3 siRNAs intracellularly to inhibit tumor growth. Our project is a first-in-
field study that galvanizes our current combined expertise and technology. The dual prostate tumor “centric”
feature of these next generation NP prototype platforms increases their specificity and efficacy, and overcomes
the limitation of conventional standard-of-care drugs, particularly in the case of acquired drug resistance.

Public health relevance
NARRATIVE Despite remarkable advances in the management of prostate cancer, no current standard of care exists to treat lethal prostate cancer phenotypes. Nanomedicines have significant potential for cancer treatment, although the majority of them developed to date and currently in clinical trials show non-specificity and low delivery to the tumor site, indicative of poor in vivo stability. Here, we propose the development a modular, antibody-targeted nanoparticle drug delivery platform that is proven to be stable in complex in vivo environments and can be engineered to optimize the efficacy and safety of lethal prostate cancer treatment regimens.